Integrin αEβ7-dependent IgA transcytosis during homeostasis and IBD

7. Project Summary
Inflammatory bowel disease (IBD) arises in genetically-susceptible individuals when the intestinal immune
system loses tolerance to unidentified elements of the commensal microbiota. Plasma cell (PC)-derived secretory
immunoglobulin A(sIgA) is one of the main mechanisms through which we are able to coexist with our
microbiota. Despite this, insufficient emphasis has been placed on understanding the B cell/immunoglobulin A
(IgA) system during IBD. Antibodies that block integrins on the cell surface of white cells have become a widely-
used strategy for the treatment of IBD. One of these drugs (vedolizumab), specifically blocks integrin α4β7, a
molecule which is critical for the traffic of white cells to the intestine. We find that B cells carry this integrin more
than T cells in mice and humans and critically depend on this molecule to traffic to intestine. Therefore, mice
that lack the β7 integrin chain have an intestinal B cell deficit and a stool IgA deficit that leads to alterations if
their intestinal flora and worse IBD in two chronic IBD mouse models. Although this could be attributed to an
integrin α4β7 defect, the luminal IgA deficit persists in mice that lack αEβ7 integrin, although in these mice B
cells can reach the intestine normally. We recently found a previously undescribed subset of intestinal PC that
express αEβ7, localized primarily to the base of the crypts. We propose that certain intestinal PC express αEβ7,
which allows them to dock with intestinal epithelial cells and directly relay IgA for its most efficient transport
to the intestinal lumen. We believe that this new mode of IgA transport plays a critical role for the maintenance
of IgA in intestinal lumen and therefore on the microbial flora during IBD. In the current proposal we will
several address important questions that remain unanswered. 1. Where are these cells located and what is their
origin? 2. How do they influence the severity of IBD in mice and 3. What is their contribution on the control of
the intestinal bacterial flora during IBD. This investigation is significant as it begins to address the role of B cells
and their critical dependence on β7 integrins to home to the intestine and maintain the required IgA levels that
control certain pathogenic microbes during IBD. Understanding the role of lymphocyte integrins at the interface
between the microbiota and its host may lead to a better understanding of how do current anti-integrin
therapeutics work and lead to new interventions to prevent the uncontrolled immune response to the microbiota
that triggers IBD.

Public health relevance
8. Project Narrative The inflammatory bowel diseases (IBD) affect over a million people in North America, cause significant morbidity and pose a significant financial burden to our healthcare system. Here, we use unique chronic mouse models of IBD and B cell function to investigate the role of a novel subset of intestinal integrin alpha E beta7 integrin-expressing plasma cells on the regulation of disease severity and control of the microbiota during experimental IBD. We believe that achieving an understanding of the cells and molecules that exert control over the microbiota might directly translate to human IBD and lead to the discovery of newer ways to treat or even prevent IBD in genetically-susceptible individuals.